Skeletal Muscle Regeneration from Pluripotent Stem Cells

Summary Pluripotent stem cells (ES and iPS cells) have the ability to self-renew and to differentiate into multiple lineages in vitro. This makes these cells a powerful tool to study early embryonic developmental pathways and to generate specific cell populations for regenerative medicine and disease investigation. Supported by R01 AR055299, our research group has pioneered methods to derive large quantities of skeletal myogenic progenitor cells from mouse and human pluripotent ES and iPS cells. Upon transplantation into dystrophic mice, these progenitors are not only able to generate new functional myofibers, but also to seed the satellite cell compartment, thus providing long-term regeneration. In the last funding period, we defined the molecular signature of in vitro- generated PS cell-derived myogenic progenitors by comparing their transcriptome profiles to those of primary skeletal myogenic progenitors isolated at different developmental stages. Our findings revealed that PS cell- derived myogenic progenitors possess a molecular signature similar to embryonic/fetal myoblasts. Paradoxically however, they differ functionally from fetal myoblasts, as PS cell-derived myogenic progenitors show much superior myofiber engraftment and ability to seed the satellite cell compartment, respond to multiple re-injuries and contribute to long-term regeneration. These results led us to hypothesize that exposure to the adult host skeletal muscle environment may induce molecular changes in transplanted cells. We found this to be the case as transcriptome analysis of PS cell-derived mononuclear cells (MNCs) re-isolated after engraftment revealed a shift in molecular signature from embryonic/fetal towards neonatal/adult stages. In this renewal application we propose studies to understand i) the interaction and molecular cues provided by the adult niche that favor the in vivo maturation of PS cell-derived myogenic progenitors, ii) the role of post-transcriptional regulation in this process, and iii) the dynamics of engraftment and the quiescence status of specific donor-derived sub-fractions.

Public health relevance
Narrative This proposal takes advantage of the ability of pluripotent stem cells to uniquely produce differentiated somatic cell types in large quantities. This allows the generation of specific cell populations for regenerative medicine. We have developed methods, based on the conditional expression of myogenic master regulators, Pax3 and Pax7, to induce the muscle program in early mesoderm, and thus derive embryonic muscle progenitors with great efficiency. Our investigations will focus on understanding the interaction and molecular cues provided by the adult niche that favor the in vivo maturation of PS cell-derived myogenic progenitors, as well as the clonal dynamics of engraftment and quiescence.